Investigating the development and clonal dynamics of broadly neutralizing B cells against influenza viruses

PROJECT SUMMARY/ABSTRACT
Broadly neutralizing antibodies against the influenza virus surface glycoprotein hemagglutinin (HA) can provide
protection from nearly all influenza viruses. However, broadly neutralizing antibodies are rarely induced by
vaccination and instead, most antibodies target variable epitopes of the influenza virus HA head domain that
only provide narrow protection against a few influenza virus strains. The fundamental mechanisms dictating B
cell immunodominance, which B cell specificities are recalled upon virus exposure, remain largely unknown. We
identified that first exposure to a novel influenza virus robustly induced antibodies against four broadly
neutralizing epitopes of HA. However, repeated exposure to the same virus preferentially drove the recruitment
of antibodies targeting variable epitopes of the HA head. Notably, my studies identified that antibodies targeting
broadly neutralizing epitopes are enriched for polyreactivity, the ability of a single antibody to bind to multiple
molecularly distinct antigens, including foreign and self-antigens. Furthermore, polyreactive naïve B cells
targeting broadly neutralizing epitopes are preferentially selected into the memory B cell pool to provide defense
against novel pandemic-threat influenza viruses. Based on my preliminary data, I hypothesize that HA epitope
specificity influences B cell development, differentiation, and inter-clonal competition, which leads to differences
in B cell immunodominance. B cell immunodominance may be dictated by three independent processes: 1) B
cells targeting broadly neutralizing epitopes may undergo clonal deletion or become anergic as a result of being
polyreactive (Aim 1), 2) B cells targeting broadly neutralizing epitopes differentiate into short-lived B cell subsets
as opposed to long-lived B cell subsets (Aim 2), and 3) B cells targeting variable epitopes outcompete B cells
targeting broadly neutralizing epitopes (Aim 3). To test these aims, I will use CRISPR/Cas9 to generate B cell
receptor knock-in mice expressing the germline version of human monoclonal antibodies targeting four broadly
neutralizing epitopes of HA and two variable epitopes of HA. To test Aim 1, I will evaluate B cell development
and B cell signaling potential of each B cell receptor knock-in line by generating mixed bone marrow chimeras.
In Aim 2, I will determine if epitope specificity shapes B cell differentiation potential by immunizing mice that
receive a B cell adoptive transfer from each B cell receptor knock-in line and tracking B cell differentiation and
affinity maturation. In Aim 3, I will determine whether B cells targeting a variable epitope outcompete B cells
targeting a broadly neutralizing epitope within the germinal center by tracking germinal center responses in HA-
immunized mice that have received adoptively transferred B cells targeting each epitope. Knowledge gained
from this research will provide critical insight into how broadly neutralizing B cells can be induced, which will aid
in the development of a universal influenza virus vaccine that can provide broad protection against all influenza
viruses. The additional training afforded by this mentored award will enable me to expand my scientific and
professional skillsets, leading to my research independence and successful transition into a faculty position.

Public health relevance
PROJECT NARRATIVE Broadly neutralizing antibodies against influenza viruses are rarely induced by influenza virus vaccination, but could provide near universal protection from all influenza viruses. The goal of this proposal is to determine if B cells targeting broadly neutralizing epitopes are cellularly distinct and developmentally disadvantaged relative to B cells targeting variable epitopes of influenza viruses. Knowledge gained by this study with reveal the underlying biology of broadly neutralizing B cells against influenza viruses and provide critical insight into how broadly neutralizing B cells can be induced by influenza virus vaccination.